Substance Use and Firearm Injuries among Medicaid-enrolled Youth

PROJECT SUMMARY/ABSTRACT:
Firearm injuries are the single leading cause of death among adolescents and young adults (“youth”) in the US.
Risk for firearm-related suicide, homicide, and other injuries rises during adolescence and into young
adulthood, as do rates of drug and alcohol use. Substance use increases the risk of firearm injuries, and
identifying and addressing substance use may be a critical strategy for preventing firearm-related morbidity
and mortality. Youth at risk for firearm injuries commonly present to healthcare settings, where evidence-based
interventions can be delivered to address substance use and prevent future injuries. However, clinicians,
health systems, and policymakers need clear data on the optimal location and timing for such interventions.
Additionally, owing to longstanding systemic inequities, youth of color experience disproportionately elevated
firearm injury rates and substance involvement, and studies to reduce firearm morbidity and mortality must
have a clear focus on health equity. The central objective of this project is to provide a comprehensive, national
picture of the links between substance use, firearm injuries, and reinjury in a sample of 42 million Medicaid-
enrolled youth aged 13-25 from across the US during 2016-2020, and throughout, to detail opportunities to
reduce disparities by race and ethnicity. The Specific Aims are to: (1) Identify substance use-related visits in
youth prior to a firearm injury, with a focus on the location and timing of such visits; and (2) Determine the
extent to which substance use is associated with risk for reinjury after an incident firearm injury. The project will
be guided by a diverse Youth and Family Advisory Board to inform protocol development, analysis,
interpretation, and dissemination of findings, with a goal of maximizing relevance and delivery of results to
youth, families, and key stakeholders across the US. Using the research project as an opportunity for mentored
experience, this K18 Career Enhancement Award will support the PI, Dr. Scott Hadland, an expert in youth
substance use, to develop new knowledge and skills in the field of firearm injury prevention. Specifically, he will
acquire foundational knowledge in firearm injury epidemiology and policy, and skills in building and partnering
with an advisory board of individuals with lived experience. The project is supported by an interdisciplinary
mentorship team with expertise across these topics, as well as in racial and ethnic disparities, and linkage and
analysis of large datasets. The variables and associations identified in this study will serve as critical inputs to
future, independently conducted research of the PI, including machine-learning models, decision analysis, and
electronic health record-based interventions.

Public health relevance
PROJECT NARRATIVE: Risk for substance use and firearm injuries increases rapidly during adolescence and into young adulthood, and intervening in substance use could prevent morbidity and mortality from firearms. This project will identify links between substance use and firearm injury/reinjury in Medicaid-enrolled youth from across the US. By pursuing a career enhancement plan and completing the proposed project, the Principal Investigator, an established clinician-scientist with expertise in youth substance use, will acquire the knowledge and skills to become a firearm researcher.